FEEDING STRATEGIES FOR LOW BIRTH WEIGHT INFANTS

The working hypothesis in this study is that specific enteral feeding strategies enhance nutritional, metabolic, and gastrointestinal maturity in the low birth weight infant and permit earlier hospital discharge.